Diagnostic utility of antibodies to post-translationally modified nucleosomes in lupus nephritis

Anti-nuclear antibodies (ANA) are used as one of the diagnostic criteria for SLE, but they display poor
diagnostic specificity for SLE (~76%), as they are also detected in 20-40% of healthy individuals and are
frequently observed in other autoimmune diseases. Anti-DNA and anti-nucleosome antibodies have been
reported to fluctuate with renal flares in several studies but they have been sub-optimal in their diagnostic
potential. Anti-nucleosome and anti-chromatin antibodies appear earlier than anti-dsDNA Abs, about 4-8
years preceding diagnosis but it is not known if additional autoantibody specificities (with higher
sensitivity/specificity values) can be detected even earlier. Ab to post-translationally modified nucleosomes
in SLE have not been comprehensively studied, and their diagnostic significance remains poorly explored.
The repertoire of ANAs targeting epigenetic, PTM nucleosomal epitopes is currently a black box. Given
that activated cells, apoptotic cells, cells undergoing netosis all release PTM-nucleosomes (that may serve
as immunogens in SLE), it is imperative that we study Abs to epigenetically modified nucleosomes in SLE
comprehensively because these fine specificities are likely to have diagnostic significance as well as
relevance to disease pathogenesis. Importantly, a 3-dimensional, spectrally resolved, fluorescent bead-
based assay pioneered by our industrial partner relieves this bottleneck.
The central hypothesis of this proposal is that autoantibodies to histone/nucleosome PTMs could exhibit
superior diagnostic potential and pathogenic relevance in lupus. The goal of this academia-industry
partnership is to test this hypothesis using a novel, high-throughput, spectrally resolved, fluorescent bead-
based screening platform bearing a comprehensive battery of PTM-nucleosomes/histones and several
well-annotated SLE cohorts.
The availability of reliable serum biomarkers that can accurately diagnose SLE and renal involvement in
SLE can prompt earlier treatment, which has been shown to improve long-term outcome. The identified
sub-nucleosomal specificities may also shed light on the pathogenic origins of SLE.

Public health relevance
The central hypothesis of this proposal is that autoantibodies to histone/nucleosome post-translational modifications could exhibit superior diagnostic potential and pathogenic relevance in lupus. The goal of this academia-industry partnership is to test this hypothesis using a novel, high-throughput, spectrally resolved, fluorescent bead-based screening platform bearing a comprehensive battery of post-translational modified nucleosomes/histones in several well-annotated lupus cohorts. The availability of reliable serum biomarkers that can accurately diagnose SLE and renal involvement in lupus can prompt earlier treatment, which has been shown to improve long-term outcome.